Protein arginine methylation in transcription and RNA metabolism

Project Summary/Abstract:
Protein arginine methylation is an abundant and evolutionarily conserved post-translational modification (PTM)
found in all eukaryotes. This process is vital for maintaining proper cellular function and normal development.
However, aberrations in protein arginine methylation can lead to a variety of human diseases, such as
neurodevelopmental disorders and cancer. Our long-term goal is to elucidate the molecular mechanism
underlying the impact of arginine methylation in gene expression and define how this regulatory process
contributes to human biology and disease. We've been pioneering this research, making significant strides in
understanding how the protein arginine methyltransferases (PRMTs) “write”, how the methylarginine effectors
“read” this PTM, and how these mechanisms work together to regulate multiple facets of gene expression, such
as transcription, RNA splicing, and RNA modification. Despite these achievements, significant knowledge gaps
still exist. While we have characterized all nine PRMTs (PRMT1-9) and identified numerous arginine-methylated
protein substrates, the molecular pathways through which arginine methylation influences gene expression are
not yet fully understood. Similarly, although we know reader proteins play a crucial role in transmitting arginine
methylation signals to downstream effects, their function and regulation via cell signaling remain somewhat
opaque. Moreover, we have yet to fully grasp the role of arginine demethylases in the reversible and dynamic
nature of this modification, which can be influenced by various environmental and cellular factors. To fill these
gaps in knowledge, our lab intends to address three fundamental questions in arginine methylation and gene
regulation through this MIRA award. Specifically, our objectives are to: 1) understand how arginine methylation
impacts cellular m6A homeostasis and gene expression, 2) determine how methylarginine readers transmit
arginine methylation signals and identify the factors that govern their activity and specificity, and 3) explore to
what extent demethylases contribute to the dynamics of arginine methylation. By answering these questions, we
anticipate gaining a more comprehensive understanding of arginine methylation and its role in gene regulation.
This could lead to potential breakthroughs in translational science, providing valuable insights for treating
diseases linked to aberrant arginine methylation.

Public health relevance
Project Narrative Our research aims to understand the role of protein arginine modification in gene regulation. Specifically, we will explore the influence of arginine methylation on m6A homeostasis, study how methylarginine readers transmit the arginine methylation signal, and investigate the contribution of arginine demethylases to the dynamics of arginine methylation. This fundamental knowledge will have broad implications for translational medicine.